Environmental regulation of bacterial growth and cell division

Project Summary
The environment is a primary determinant of bacterial growth and behavior. It impacts not only metabolism and
growth rate, but also morphology, development, and antibiotic susceptibility. Our research centers on the
essential processes that coordinate cell growth and cell cycle progression with the environment. In bacteria
these processes are critical, maximizing proliferative potential across a wide physicochemical landscape.
Defects in these processes can be catastrophic, impairing growth, reducing viability, and rendering cells
hypersensitive to antimicrobials. The increasing prevalence of antibiotic resistant pathogens provides a
powerful motivation for our work. Understanding how bacteria adapt to the physicochemical environment
should reveal novel approaches for the treatment of bacterial pathogens and identify targets for the
development of next-generation therapeutics. In this this effort we employ evolutionarily distinct organisms
including two Gram-negative Gammaproteobacteria: the model organism Escherichia coli and the pathogen
Klebsiella pneumoniae. In 2019 K. pneumoniae was the third leading cause of global deaths due to or
associated with antibiotic resistance (Lancet, 2022).
The cell envelope is vital to bacterial viability, required as both a permeability barrier and a buttress
against turgor pressure. Exposed to the environment, essential cell envelope processes must remain functional
across a large range of conditions. Understanding the factors that underlie and preserve cell envelope integrity
is a primary research focus. Extending our finding that functional redundancy amongst E. coli cell wall
enzymes ensures robust growth across pH values, we will use single molecule techniques and biochemistry to
illuminate the impact of pH on the activity of individual PBP transpeptidases in situ. These enzymes play a
critical role in peptidoglycan cross linking and are the target of beta-lactam antibiotics. We will also identify
factors underlying pH-mediated changes in cell wall synthase activity and beta-lactam resistance in K.
pneumoniae. As part of a broader effort to understand the mechanisms coordinating cell envelope biogenesis
with cell growth and cell cycle progression, we will elucidate the essential role of the outer membrane
component lipopolysaccharide (LPS) in E. coli biology. Finally, building on our longstanding interest in the
relationship between nutrient availability and cell morphology, we will characterize the mechanisms governing
a newly identified starvation-mediated stress response, cytoplasmic condensation, and identify the effector(s)
responsible for the positive relationship between the starvation-associated alarmone, ppGpp, and cell division.
We are aided in these endeavors by our multidisciplinary approach that employs a diverse array of
techniques, as well as an extensive network of close colleagues and collaborators with whom we enjoy a free
exchange of reagents and ideas. These advantages allow us to answer previously intractable questions in
physiology and homeostatic control that are relevant to organisms throughout the tree of life.

Public health relevance
Project Narrative Our research centers on the essential processes coordinating the environment with cell growth and cell cycle progression in bacteria. Environmental variables dictate not only metabolic status and growth rate, but also morphology, development, and antibiotic sensitivity. Illuminating the regulatory circuits governing the relationship between the environment and bacterial physiology is essential to understand their contribution to antibiotic resistance and to assist in the design and development of approaches to defeat this problem.